Zone-specific mitochondrial functions in regulation of hepatic metabolism

.SUMMARY – R21 – Newgard .
Aging and overnutrition have deleterious effects on liver health, including development of mitochondrial
dysfunction. The liver is divided into distinct zones (Zone 1–Zone 3), each enriched in a discrete subset of
metabolic pathways, but little is known about how aging and metabolic stress affect zone-specific mitochondrial
metabolic or respiratory functions. Using a powerful suite of technologies, including mice engineered for zone-
specific expression of an immunoisolation tag (MITO-Tag) that allows purification of mitochondria in <10
minutes, sophisticated metabolomic and metabolic flux analysis tools, mitochondrial respiratory assays, and
in vivo CRISPR gene discovery technologies, we will (i) optimize our workflow for use of MITO-Tag for rapid
isolation of mitochondria from liver at high yield and with full metabolic functionality (Aim 1); ii) develop zone-
specific MITO-Tag mice to allow a comprehensive view of metabolism and energetics in mitochondria isolated
from different liver zones (Aim 2); (iii) deploy two in vivo CRISPR screening approaches, including a novel
method designed in our laboratory, to identify mitochondrial genes that impact hepatocellular fitness during
nutritional stress (Aim 3). By understanding exactly how metabolism is partitioned across zones in primary liver
cells, and by identifying genes via our CRISPR screens that enhance the well-being of liver cells in each zone,
we can contribute to development of novel therapies for the growing pandemic of liver dysfunction in the rapidly
aging US population.

Public health relevance
.PROJECT NARRATIVE – R21 – Newgard . The liver exhibits zonal heterogeneity in metabolic functions, but how these change in response to age and overnutrition is poorly understood. Here we will define zone-specific mitochondrial metabolic and energetic functions, and identify genes that enhance hepatocellular fitness across zones.